Human iPSC intestine mimetics with integrated mesenchymal, endothelial and enteric nervous tissue

In this proposal, we present exciting preliminary data showing that we have generated an iPSC-derived human
intestinal organoid (HIO) model that co-differentiates a complex multilineage tissue that possesses epithelium,
a mesenchymal/stromal layer that includes organized smooth muscle, endothelial cells and enteric neurons.
This is the first complex HIO model from iPSCs to spontaneously co-differentiate tissues from all 3 embryonic
germ layers, which is a prerequisite for a fully formed and functional organ, and the phenotype is driven by
specific members of the EGF-family of grow factors that are supplied as niche factors in the HIO growth
medium. The goals of this proposal is to interrogate the development of the complex lineages present in
complex HIOs (Aim 1), to further enhance the organization and complexity of HIOs by using a novel
suspension culture method and via in vivo transplantation (Aim 2), and to functionally interrogate the vascular
and neuronal cells present complex HIOs using microfluidics and in vivo transplantation (Aim 3).

Public health relevance
There is a great unmet need for human model systems to study biological processes involving complex interactions between diverse tissues within an organ. For example, there are many physiopathological processes related to the human intestine that involve cross-talk between tissue types, such as Hirschsprung’s disease, which is a congenital lack of enteric neurons affecting 1 in 5,000 births, that renders smooth muscle within the gut unable to contract. We present compelling preliminary data for a novel iPSC-derived human intestinal organoid (HIO) model that can co-differentiate as a complex multilineage tissue possessing an epithelium, a mesenchymal/stromal layer that includes organized smooth muscle, endothelial cells and enteric neurons - the first complex HIO model from iPSCs to co-differentiate tissues from all 3 embryonic germ layers in one model system.